Engineering astroglial bridges for axons across severe SCI lesions

Anatomically complete spinal cord injury (SCI) transects and eliminates all functional connections across
the level of the lesion, and in adults, axons fail to regrow spontaneously across such lesions. Restoring
voluntary control of function will require interventions to establish new neural connections across the
lesion. During the previous funding cycle of this grant, we identified a mechanism-based biological repair
strategy for achieving robust regrowth of propriospinal axons across complete SCI lesions in rodents.
We showed that providing three mechanisms essential for axon growth during development, (i) neuron
intrinsic growth capacity, (ii) growth-supportive substrate and (iii) chemoattraction, can achieve robust
regrowth of axons through and beyond anatomically complete SCI. This axon regrowth was 100-fold
greater than controls, passed a full spinal segment beyond the injuries, and was able to restore
significant electrophysiological conduction capacity across injuries. To achieve the spatially and
temporally controlled in vivo molecular delivery required to realize this axon regrowth, we engineered
biomaterial depots that enabled us to mimic certain spatiotemporal events regulating axon growth during
development. In the project proposed here, we will build on this work and use our newly developed
synthetic hydrogel vehicle to deliver molecules that direct the differentiation in vivo of grafted neural
progenitor cells (NPC) into axon-supportive immature astroglia that repopulate non-neural lesion cores
and reestablish a multicellular neural environment favorable for long term support of host propriospinal
axons chemoattracted to regrow through lesions into spared neural tissue. Our hypothesis is that
repopulating (and ‘reneuralizing’) such non-neural lesion cores, or their cysts, with immature astroglia will
promote long-term axonal maintenance and provide a favorable niche for remyelinating cells. Our
objective is to develop engineering approaches that facilitate doing so. Our premise is that our hydrogel
vehicles can deliver both: (i) molecules that direct the differentiation of NPC in vivo, and (ii) molecules
that chemoattract host axons. Our past work and preliminary data show that NPC grafted in our hydrogel
vehicles are good candidates to generate support cells for host axons as well as for host-derived
oligodendrocyte progenitor cells that migrate into areas of grafted cells. We have also shown that
propriospinal neurons are good targets for bridging host axons across complete SCI lesions into spared
neural tissue below injuries. The work for this proposal will advance the development of mechanism-
based engineering approaches to repair neural tissue after severe SCI, stroke and other CNS disorders
with large focal lesions.

Public health relevance
Spinal cord injury (SCI) is a major cause of long term disability with devastating consequences for the individual and a substantial economic burden to society. One important strategy for improving outcome after SCI is to stimulate nerve fibers (axons) to regrow across lesions to form new connections. In this project, we continue and expand our development of biomaterials that: (i) can easily and safely be injected into the spinal cord to deliver molecules that stimulate and guide axon growth through SCI lesions to reach neural targets in healthy tissue, (ii) have safety profiles compatible with clinical translation, and (iii) can serve as vehicles for neural stem cells grafts that can be directed to form neural support cells called glia, which can support and maintain regrowing axons.